INTERNAL AND EXTERNAL COMMUNICATIONS AND DISSEMINATION SUPPORT FOR DCCPS

The National Cancer Institute (NCI) has created smoking cessation and other behavioral health services for multiple population groups and diverse audiences. NCI needs to provide support for the ongoing development and maturation of these services, adoption within the public health community and among target audiences, and engagement with research communities to continue to evolve and advance mobile health interventions and the awareness of them.

Independently and not as an agent of the Government, the Contractor shall furnish all the necessary services, qualified personnel, material, equipment, and facilities, not otherwise provided by the Government as needed to perform the Statement of Work.

The primary objectives of this task are to provide engagement and outreach support to internal and external audiences to help set and refine research agendas, improve awareness of NCI research and availability of NCI-developed tools to support research efforts by grantees and other partners; reach target audiences through partnerships, as well as earned, paid, and other outreach efforts; measure the impact of these efforts and provide analysis and insights that may be used in similar future efforts.